Molecular and Cellular Regulation of Uterine Morphogenesis

Project Summary
In mammals, the uterus serves many functions including a passage for spermatozoa, embryo implantation, and
fetal gestation. Congenital uterine anomalies are present in 25% of women with a history of miscarriage and
infertility. It has been increasingly noted that uterine anomalies are simultaneously present with reproductive
diseases. For this reason, it is necessary to further understand female reproductive development to better
manage and prevent reproductive diseases in women. The female reproductive tract develops from a pair of
epithelial tubes called the Müllerian ducts (MD). During embryonic development, the Müllerian ducts and
adjacent mesenchyme differentiate into the oviducts, uterus, cervix, and upper part of the vagina. In many
mammals, the MD must fuse at the midline for proper uterine morphogenesis. Formation of the uterus occurs
with the differentiation, invagination, elongation, and fusion first, of the MD to the urogenital sinus (UGS) and
secondly, the two MD fuse to each other at the body midline during uterine morphogenesis. Any divergence in
MD fusion during human development can lead to uterine variation that may prevent a healthy pregnancy or
delivery of a newborn. While there have been many studies on MD formation, it is currently unknown which
genes and molecular mechanisms regulate the fusion of the MD ducts. Preliminary data from our lab shows
that Wnt7a knockout mice have uterine abnormalities as a result of unfused MD, suggesting an essential role
for Wnt7a in fusion of the two MD. Currently, the cellular behaviors and mechanisms that regulate MD fusion
are poorly understood. The crosstalk between MD epithelium with the adjacent mesenchyme has not been
studied in the context of MD fusion. In Aim 1, I will use ex vivo organ culture time-lapse imaging and
immunofluorescence staining to determine which cellular changes coordinate MD fusion. In Aim 2, I will use
spatial transcriptomics to identify differentially expressed genes downstream of Wnt7a, using wild-type and
Wnt7a knockout embryos. The objective of this proposal is to determine the precise timing, position, and length
of MD fusion, what cellular changes occur during MD fusion, and the downstream genes of Wnt7a that govern
MD fusion for uterine morphogenesis. Our primary hypothesis is that Wnt7a directs the crosstalk between
MD epithelium with the adjacent mesenchyme to instruct MD fusion to form a portion the uterus. The
Behringer laboratory located at MD Anderson in the Texas Medical Center has expertise in reproductive
biology, mammalian developmental genetics, and mouse genetic models. During my graduate training, I will
meet with my Sponsor biweekly, advisory committee as a group biannually, and with experts on the subject
individually as needed. I have written a chapter review and will write two first-author publications summarizing
my findings. I will present my work at both my graduate program seminars and at two national conferences
annually. Ultimately this work will facilitate my long-term goals of conducting my postdoctoral studies in
reproductive sciences and becoming an independent reproductive biology researcher.

Public health relevance
Project Narrative The long-term goal of my studies is to understand uterine morphogenesis, an important process for forming a uterus capable of carrying a pregnancy to term. My proposed experiments will identify molecular and cellular mechanisms that regulate mammalian uterine formation and will help shed light into the causes of gynecological disorders and diseases.